Molecular Mechanisms of TULP1-Mediated Photoreceptor Degeneration

Abstract.
Mutations in the TULP1 gene underlie a severe, early-onset form of autosomal recessive retinitis
pigmentosa (RP). Our long-term objectives are to understand the cellular function of TULP1 and the
pathogenic mechanism responsible for retinal degeneration. TULP1 is a photoreceptor-specific protein
involved in vesicular trafficking in two photoreceptor compartments. In tulp1-/- mice, several phototransduction
proteins are mislocalized, indicating that TULP1 is necessary for protein transport to the outer segment (OS).
These mice also have a synaptic malformation with few intact ribbons, indicating a defect in neurotransmitter
vesicular cycling. Our preliminary data indicates that TULP1 has two distinct interactomes. We postulate that
TULP1 functions as an adapter protein linking OS-bound protein transport vesicles to the axoneme of the
transition zone and neurotransmitter-filled vesicles to the ribbon complex. Preliminary studies done in vitro
suggest that mutant TULP1 proteins cause ER stress and leads to induction of the unfolded protein response
(UPR) pathway, suggesting a possible mechanism for cell death. Our overall hypothesis is that TULP1 is a
phospholipid-sensing adapter protein required for the vesicular transport of proteins and that mutant
forms of TULP1 cause protein mistrafficking which induces chronic ER stress leading to photoreceptor
cell death through overload of protein degradation pathways. Experiments in Aim 1 will identify TULP1
compartment-specific protein-protein interactions and whether these interacting networks are disrupted by RP-
associated TULP1 mutations. This will be accomplished by performing immunoprecipitations, localization
experiments, high-resolution imaging, proximity proteomics and quantitative cross-linking mass spectroscopy
methods. Experiments in Aim 2 will determine the molecular signatures, temporal contributions and
mechanism of stress response pathway(s) activation throughout disease progression in Tulp1 mutant models
of RP by analyzing molecular markers unique to each pathway. For these experiments, we generated two
novel knock-in mouse lines each expressing an RP-associated TULP1 missense mutation. WT, tulp1-/-,
tulp1D94Y and tulp1F491L mice will be crossed with three different mouse lines each expressing an in vivo reporter
gene relevant to UPR, proteasome activity, or autophagy. Comprehensive phenotypic analyses will be
performed and compared across mice to determine in vivo whether mutant Tulp1 proteins induce chronic ER
stress leading to activation of stress response pathways causing cell death by overwhelming the
photoreceptors proteostasis network capacity. By clarifying the proteins involved in vesicular trafficking, this
project will significantly impact an important aspect of photoreceptor biology relevant to human retinal function
and disease. Importantly, determining the pathogenic mechanism behind TULP1-associated RP and identifying
the activated pathways will aid in discovering therapeutic targets aimed at slowing this blinding condition.

Public health relevance
Project Narrative. Mutations in the photoreceptor-specific TULP1 gene cause an early-onset and severe form of retinitis pigmentosa, an inherited form of blindness. The first goal of this research project is to identify the function of Tulp1 and determine the complement of proteins comprising the Tulp1 complex and how these interactions combine to assemble the machinery required to transport photoreceptor proteins. The second goal is to define the pathological mechanism causing photoreceptor degeneration due to TULP1 mutations thereby identifying pathways as specific targets for therapeutic intervention aimed at slowing this blinding condition.